Mechanisms and Impact of Pregnancy-Induced Adaptations in Pelvic Floor Muscles

PROJECT SUMMARY
Our proposal exemplifies the NIH vision that the multidisciplinary approach to clinical care and research is the
most fruitful paradigm for the development of significant advancements within a specific field. While it is
unfortunate that the heavy focus of skeletal muscle research on the appendicular muscles in male animal models
led to scarcity of preclinical investigations in the area of female pelvic skeletal muscles and provided little
progress toward preventative or therapeutic approaches that target female-specific conditions, such as pelvic
floor disorders; the current project builds on the discoveries of the landmark studies conducted in the limb
muscles. Here, we focus on building the foundational knowledge pertaining to female pelvic floor muscle -specific
muscle stem cells and the impact of such critical time-periods as pregnancy and childbirth on these cells. The
above is necessary for future development of pragmatic preventative approaches to reduce the impact of morbid
pelvic floor disorders on public health. This project represents a novel approach focused on elucidating the role
of muscle stem cells in pregnancy-induced antepartum adaptations of the pelvic floor muscles as well as muscle
regenerative potential following vaginal delivery. To achieve this objective, we will use our validated experimental
model to examine the phenotypic, functional, transcriptional, and epigenomic signatures of pelvic muscle stem
cells at multiple time points across gestation, parturition, and postpartum period to identify candidate signaling
pathways regulating their functional state. We will then test whether exposure to different aspects of the ante-
and peripartum environment modulates the regenerative potential of pelvic muscle stem cells and impacts
muscle recovery following injury. Overall, this innovative study will provide fundamental insights into the
biological processes involved in the regulation of female pelvic muscle satellite cells and factors that impact their
regenerative capacity following mechanical injury. The resulting knowledge will enable the development of novel
strategies to prevent or treat female pelvic muscle dysfunction.

Public health relevance
PROJECT NARRATIVE Mechanical birth injury to maternal pelvic soft tissues, including pelvic skeletal muscles, is the strongest potentially preventable risk factor for long-term pelvic floor dysfunction. This project, conducted in a preclinical model validated for the studies of human pelvic muscles, will have an impact on public health by delineating the adaptive and repair mechanisms of the female pelvic muscles, with specific focus on the biological processes that regulate the functional state of endogenous muscle stem cells during pregnancy - one of the most transformative non-pathological periods along the lifespan of many women. The knowledge gained from this proposal will lead to potential new preventative strategies and therapies for enhancing pelvic skeletal muscle plasticity and improving muscle recovery following mechanical injury.